Methods Core

CAPES METHODS CORE: PROJECT SUMMARY/ABSTRACT
Significance: The CAPES Methods Core has dual goals of: (1) supporting transdisciplinary team science for all
CAPES research by providing methodological expertise and technical support, and (2) serving as an incubator
for generating new methods in practice-based suicide prevention care technology and implementation research.
The Core’s significance rests on a combination of: (a) state-of-the-art methods built into the four proposed
projects that support their individual scientific and public health impact, (b) opportunities for the Methods Core to
synthesize data and learnings across projects, and (c) advancement of methods for suicide research.
Innovation: The Methods Core will innovate through: (1) building and applying innovative, highly efficient
implementation study designs, (2) fostering a common implementation science framework and measurement,
(3) exploring the synergy between classical statistical and machine learning analytic approaches, and (4)
innovating suicide care technology development and user testing.
Approach: The Methods Core will be co-led by a physician-scientist and methodologist (Kiefe, CAPES Co-
Directors), a computer scientist and engineer (Agu), and a biostatistician and psychometrician (Yang). Core
faculty have expertise in implementation science, biostatistics, psychometrics, epidemiology, health economics,
health services research, person-centered design, artificial intelligence, machine learning, and healthcare
industrial engineering. The Core is organized into six Units, and Core scientists are embedded into each project
team. The Core has the following Specific Aims:
Aim 1. Provide methodological expertise and technical support to all CAPES projects.
Aim 2. Advance analytic and implementation methods to study adoption of technologies and methods enabling
improved practice-based suicide-related research and care. Example: Innovative design of the Signature Project,
which will be an Efficacy/Effectiveness/Implementation hybrid.
Aim 3. Create guidance on best practices in health system adoption of technologies that enable suicide care
and operationalize how the technologies can facilitate adoption through cross-project knowledge aggregation.
Example: production of the EHR Best Practice Guide to Implementing Zero Suicide for EHR vendors and health
systems.
Aim 4. Together with the Administrative Core, evaluate all CAPES research and training activities and broadly
disseminate CAPES findings, methodological advances, and other resources based on a Logic Model for
evaluation and multi-channel dissemination approaches to diverse stakeholders.
Impact: CAPES in general, and the Methods Core in particular, will transform the way that technology is used
to aid and augment suicide prevention clinical practice and research. The Methods Core will also become a
national resource for the implementation of suicide prevention-related technology.

Public health relevance
CAPES METHODS CORE: PROJECT NARRATIVE See Project Narrative in the Overall component.